Intersectional Stigma, Belongingness, and Suicide: A Novel Approach for Minority Mental Health.

PROJECT SUMMARY
A critical barrier to progress in the fields of suicide research and minority mental health disparities is the lack of
appropriate conceptualization of at-risk groups. Past research indicates that immigrant generation is a more
meaningful measure of suicidality than racial/ethnic categorization. Based on comprehensive findings from the
National Latino and Asian American Study, suicide is a growing concern particularly among second-generation
immigrants. Half of all second-generation immigrants are racial/ethnic minorities, namely Latinos and Asians.
Asians are the only racial/ethnic group for which suicide is the leading cause of death among early adults age
18-24. Among racial/ethnic minorities, suicide remains a top five leading cause of death until age 55 only in
Asians. Despite this disparity, there is a severe dearth of evidence-based research initiatives targeting suicide
through an identity-based approach in racial/ethnic minority groups. Past evidence from minority stress theory
suggests strong associations between identity-based stigma and suicide. However, minority stress theory lacks
an intersectional stigma perspective incorporating multiple minority identities. Adapting this theory to include
intersectional stigma enhances its applicability to racial/ethnic minorities, many of whom identify with multiple
stigmatized subgroups. Moreover, merging the interpersonal theory of suicide to minority stress allows scientists
to investigate the pathway of belongingness to suicide from an intersectional stigma perspective. The proposed
study signifies a pressing research opportunity to uncover new insights on understanding suicide through this
innovative theoretical framework in a subgroup of Asians. This will be implemented in a pilot study using a novel
study design integrating complex methods from multi-level national, community, and individual data. The study
purpose is to better understand belongingness as it relates to suicide from the complex perspective of
intersectional stigma, particularly in early adult Asians who identify with multiple stigmatized subgroups (ethnicity,
immigrant, faith), through the following aims: Aim 1: To test the potential mediating effect of belongingness to
intersectional stigma and suicide-related outcomes (stress, depression, suicidal ideation) in a national sample of
Asians with multiple stigmatized identities; Aim 2: Identify identity-specific (ethnicity, immigrant, faith) risk and
resilience factors of suicidality in an Asian community; Aim 3: Explore the meaning of belongingness from the
lived experience of intersectional stigma through in-depth interviews with Asian individuals. The fellowship
research objective is to conduct a hypothesis-generating pilot study on the risk and resilience factors of suicide
using a novel approach that is especially relevant to racial minorities. The fellowship training goals are to: (1)
gain proficiency in advanced methodological skills for mental health and health disparities research; (2) enhance
expertise in conducting suicide and mental health research in immigrant racial/ethnic minority groups; and (3)
Publish 5 first author peer-reviewed manuscripts to advance an independent research career. The proposed
study responds to NIMHD’s recent calls to produce innovative approaches for minority health disparities.

Public health relevance
PROJECT NARRATIVE Addressing a critical theoretical gap and methodological approach in suicide etiology, this research seeks to understand risk and resilience factors of suicide and collective stress from an intersectional stigma and belongingness perspective in a second-generation immigrant South Asian Muslim American community. Through a multi-level ecological study design and multi-method approach, the study seeks to advance scientific knowledge on how individuals who identify with multiple subgroups experience stigmatization and negotiate belongingness in order to produce transferable insights across minority groups as they pertain to suicide-related outcomes. Findings address a high-priority goal of Mental Health and Mental Disorders’ Healthy People 2030 by producing data on community-specific psychosocial factors of suicide etiology from a unique intersectional stigma perspective, with implications to shape how researchers think about minority mental health disparities.